SHP2's Regulation of the Bone Marrow Stroma and Hematopoietic Crosstalk

(PLEASE KEEP IN WORD, DO NOT PDF) (Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.)
It has been reported that depletion of RUNX21 or LepR2 in mesenchymal stem/progenitor cells (MSPCs) reduces bone mass and increases bone marrow (BM) adipocytes (BMA), and that PDGFRβ activation drives MSPC expansion and BM vasculogenesis, finally influencing hematopoiesis3. Our preliminary data show that mice lacking SHP2 in the Osterix+ stromal progenitor cells (O+SPCs) have similarly increased BMA and BM vasculature and skewed lymphopoiesis. We have not yet determined the molecular mechanism(s) by which SHP2 exerts its influence on O+SPCs and hematopoietic cells. However, the phenotypic similarity of mice lacking SHP2, RUNX2, LepR, or PDGFR in O+SPCs leads us to hypothesize that SHP2 influences the osteogenic, adipogenic and/or stromogenic fate of O+SPCs by modifying the transcription activity of RUNX2 and the kinase activity of PDGFR, and that altered BM O+SPCs change the cellular and molecular constituents of the BM niche and subsequently hematopoiesis. To test this novel hypothesis, we will complete two specific aims. In Aim 1 we will interrogate the impact of SHP2 depletion on RUNX2 transcriptional activity in O+SPCs, while in Aim 2 we will determine the effect of SHP2 depletion on stromogenic differentiation of O+SPCs and hematopoisis in vitro and in vivo. O+SPCs participate in BM hematopoietic niche construction and maintenance, and both SHP2 and RUNX2 influence O+SPCs. This innovative study will yield foundational information regarding SHP2’s regulatory role in O+SPCs and its consequent role in hematopoiesis and BM vasculogenesis. This information will significantly advance our understanding of the effect and importance of crosstalk between BM stromal cells and hematopoietic cells, and hematopoietic malignancy.

Public health relevance
SHP2 mutations are associated with several hematopoietic disorders, to which the underlying molecular and cellular mechanism remains elusive. Understanding how BM mesenchymal niches and BM vasculature are regulated by SHP2 and RUNX2 will greatly advance our knowledge regarding hematopoiesis regulation and it will be instrumental to the development of novel therapeutics. References 1 Tosa, I. et al. Postnatal Runx2 deletion leads to low bone mass and adipocyte accumulation in mice bone tissues. Biochem Biophys Res Commun 516, 1229-1233 (2019). https://doi.org:10.1016/j.bbrc.2019.07.014 2 Yue, R., Zhou, B. O., Shimada, I. S., Zhao, Z. & Morrison, S. J. Leptin Receptor Promotes Adipogenesis and Reduces Osteogenesis by Regulating Mesenchymal Stromal Cells in Adult Bone Marrow. Cell Stem Cell 18, 782-796 (2016). https://doi.org:10.1016/j.stem.2016.02.015 3 Bohm, A. M. et al. Activation of Skeletal Stem and Progenitor Cells for Bone Regeneration Is Driven by PDGFRbeta Signaling. Developmental cell 51, 236-254 e212 (2019). https://doi.org:10.1016/j.devcel.2019.08.013 4 Ding, L. & Morrison, S. J. Haematopoietic stem cells and early lymphoid progenitors occupy distinct bone marrow niches. Nature 495, 231-235 (2013). https://doi.org:10.1038/nature11885 5 Ding, L., Saunders, T. L., Enikolopov, G. & Morrison, S. J. Endothelial and perivascular cells maintain haematopoietic stem cells. Nature 481, 457-462 %U http://www.ncbi.nlm.nih.gov/pubmed/22281595 (2012). 6 Mizoguchi, T. et al. Osterix marks distinct waves of primitive and definitive stromal progenitors during bone marrow development. Developmental cell 29, 340-349 (2014). https://doi.org:10.1016/j.devcel.2014.03.013 7 Liu, Y. et al. Osterix-cre labeled progenitor cells contribute to the formation and maintenance of the bone marrow stroma. PLoS One 8, e71318 (2013). https://doi.org:10.1371/journal.pone.0071318 8 Chan, C. K. et al. Endochondral ossification is required for haematopoietic stem-cell niche formation. Nature 457, 490-494 (2009). https://doi.org:10.1038/nature07547 9 Omatsu, Y. The essential functions of adipo-osteogenic progenitors as the hematopoietic stem and progenitor cell niche. Immunity 33 (2010). https://doi.org:10.1016/j.immuni.2010.08.017 10 Morikawa, S. et al. Prospective identification, isolation, and systemic transplantation of multipotent mesenchymal stem cells in murine bone marrow. J Exp Med 206, 2483-2496 (2009). https://doi.org:10.1084/jem.20091046 11 Greenbaum, A. et al. CXCL12 in early mesenchymal progenitors is required for haematopoietic stem-cell maintenance. Nature 495, 227-230 (2013). https://doi.org:10.1038/nature11926 12 Pinho, S. et al. PDGFRalpha and CD51 mark human nestin+ sphere-forming mesenchymal stem cells capable of hematopoietic progenitor cell expansion. J Exp Med 210, 1351-1367 (2013). https://doi.org:10.1084/jem.20122252 13 Ornitz, D. M. & Marie, P. J. Fibroblast growth factors in skeletal development. Curr Top Dev Biol 133, 195-234 (2019). https://doi.org:10.1016/bs.ctdb.2018.11.020 14 Kim, J. M. et al. The ERK MAPK Pathway Is Essential for Skeletal Development and Homeostasis. International journal of molecular sciences 20 (2019). https://doi.org:10.3390/ijms20081803 15 Yang, H., Wang, L., Shigley, C. & Yang, W. Protein tyrosine phosphatases in skeletal development and diseases. Bone Res 10, 10 (2022). https://doi.org:10.1038/s41413-021-00181-x 16 Segaliny, A. I., Tellez-Gabriel, M., Heymann, M. F. & Heymann, D. Receptor tyrosine kinases: Characterisation, mechanism of action and therapeutic interests for bone cancers. J Bone Oncol 4, 1-12 (2015). https://doi.org:10.1016/j.jbo.2015.01.001 17 Ornitz, D. M. & Marie, P. J. Fibroblast growth factor signaling in skeletal development and disease. Genes Dev 29, 1463-1486 (2015). https://doi.org:10.1101/gad.266551.115 18 Lahiry, P., Torkamani, A., Schork, N. J. & Hegele, R. A. Kinase mutations in human disease: interpreting genotype-phenotype relationships. Nature reviews. Genetics 11, 60-74 (2010). https://doi.org:10.1038/nrg2707 19 Zuo, C. et al. SHP2 regulates skeletal cell fate by modifying SOX9 expression and transcriptional activity. Bone Res 6, 12 (2018). https://doi.org:10.1038/s41413-018-0013-z 20 Dong, L. et al. Leukaemogenic effects of Ptpn11 activating mutations in the stem cell microenvironment. Nature 539, 304-308 (2016). https://doi.org:10.1038/nature20131 21 Yang, M. et al. Osteogenic Factor Runx2 Marks a Subset of Leptin Receptor-Positive Cells that Sit Atop the Bone Marrow Stromal Cell Hierarchy. Sci Rep 7, 4928 (2017). https://doi.org:10.1038/s41598-017-05401-1 22 Zhou, B. O., Yue, R., Murphy, M. M., Peyer, J. G. & Morrison, S. J. Leptin-receptor-expressing mesenchymal stromal cells represent the main source of bone formed by adult bone marrow. Cell Stem Cell 15, 154-168 (2014). https://doi.org:10.1016/j.stem.2014.06.008 23 Shen, R. et al. Cyclin D1-cdk4 induce runx2 ubiquitination and degradation. J Biol Chem 281, 16347-16353 (2006). https://doi.org:10.1074/jbc.M603439200 24 Vimalraj, S., Arumugam, B., Miranda, P. J. & Selvamurugan, N. Runx2: Structure, function, and phosphorylation in osteoblast differentiation. Int J Biol Macromol 78, 202-208 (2015). https://doi.org:10.1016/j.ijbiomac.2015.04.008 25 Jonason, J. H., Xiao, G., Zhang, M., Xing, L. & Chen, D. Post-translational Regulation of Runx2 in Bone and Cartilage. Journal of dental research 88, 693-703 (2009). https://doi.org:10.1177/0022034509341629 26 Huang, H. et al. A Src family kinase-Shp2 axis controls RUNX1 activity in megakaryocyte and T-lymphocyte differentiation. Genes Dev 26, 1587-1601 (2012). https://doi.org:10.1101/gad.192054.112 27 Batth, T. S. et al. Large-Scale Phosphoproteomics Reveals Shp-2 Phosphatase-Dependent Regulators of Pdgf Receptor Signaling. Cell Rep 22, 2784-2796 (2018). https://doi.org:10.1016/j.celrep.2018.02.038